How are Regenerating Axons Guided in the Adult Nervous System

PROJECT SUMMARY
Common nerve injuries often lead to long-term disabilities in the central nervous system and in the peripheral
nervous system with increased adult age. Understanding how axon guidance is regulated in the mature nervous
system is critical to understanding how the nervous system changes after development and to developing
therapies aimed at reestablishing proper neural circuitry across lesions. Caenorhabditis elegans is a highly
tractable model to dissect conserved molecular and cellular mechanisms that regulate axon regeneration and
axon guidance. With this system, I have identified an extracellular matrix protein that guides regenerating motor
axons specifically in the post-development nervous system and is required for functional recovery. I will apply
my developing skills in detailed genetic analyses, laser axotomy, in vivo imaging, sequencing, and bioinformatics
to further determine the post-developmental specific role of this protein in axon guidance. In addition to
providing a critical advance in understanding the fundamental mechanisms of axon guidance, it will also inform
future therapeutic approaches that can be manipulated to promote targeted axon guidance in the injured adult
nervous system.

Public health relevance
PROJECT NARRATIVE Regenerating axons are often misguided in the post-development mammalian peripheral nervous system, as are axons that are manipulated to regenerate in the central nervous system, resulting in long-term disability. Approaches that efficiently elucidate cellular mechanisms that elicit successful axon guidance in the post- development nervous system are urgently needed. My goal is to use the highly tractable Caenorhabditis elegans model system, in which regenerating motor axons are accurately guided to their targets, to unravel molecular guidance mechanisms that function specifically in the injured adult nervous system.